Vocal cord tissue engineering: Pre-clinical scale-up

Veterans suffering loss of the larynx's vocal fold cover due to trauma or laryngeal cancer can suffer disabling voice difficulties, and treatment options are limited. A vibrating replacement tissue would revolutionize the treatment of laryngeal disorders. The work described in this proposal characterizes and optimizes a tissue-engineered Cell-based Outer Vocal cord Replacement (COVR). Adult human multipotent cells isolated from adipose tissue are cultured within fibrin hydrogel derived from the blood product cryoprecipitate. The result is a completely autologous three-dimensional tissue substitute. Upon implantation in rabbits, this construct healed well and produced normal short-term vibration for voicing. The COVR construct will now be introduced in a large animal model in preparation for human translation. This proposed research will assess the feasibility, safety, and efficacy of the tissue-engineered implant. Mechanisms of action will also be assessed by determining the fate of the implanted cells, and the effect on extracellular matrix and inflammation. Human cells will be implanted with immunosuppression. A canine model is planned because extensive prior laryngeal work has been performed in canines, providing ample data on normal phonation. If canines are impossible, a porcine model would also allow scale-up to large mammals and detailed study of the wound healing. Completion of the proposed research will determine whether the COVR meets safety and efficacy requirements to proceed with a larger trial. The goal is to restore normal voicing without adverse events. If successful outcomes occur in this pilot study, a larger trial will be performed with the intention of generating pre-clinical data for FDA application.

Public health relevance
Vocal folds are the vibrating parts of the human larynx that produce voice. Vocal folds can be damaged from a number of injuries, including surgeries for laryngeal cancer or non-cancerous masses, radiation therapy for other head and neck cancers, smoke or chemical inhalation injuries, and chronic severe acid reflux. Once the vocal folds are scarred, there is little that can be done to restore their vibration. Veterans with vocal fold injuries can suffer disabling voice difficulties with poor voice quality and vocal fatigue. The communication impairment limits social interactions and job opportunities. This project aims to develop an implantable vibrating replacement tissue to restore voice for these Veterans.